Leadership, Planning and Evaluation

PROJECT SUMMARY/ABSTRACT
LEADERSHIP, PLANNING, AND EVALUATION
Executive Director Suresh Ramalingam, MD, provides the overall strategic direction for Winship and oversees
a rigorous planning and evaluation process. Ramalingam established a strong leadership team whose members
serve as trusted advisors and leaders to support the development and achievement of Winship's strategic goals.
During the current funding period, this team has expanded to include key experts for community outreach and
engagement (COE), diversity, equity, and inclusion (DEI), and training and education (CRTEC). The Winship
executive team is now composed of the Executive Director, Deputy Director, five associate directors, a Chief
Diversity Officer, five senior advisors, and two at-large positions. Together the leadership team has led the
continued growth in Winship's research programs, shared resources, clinical research, and clinical operations.
Continuous planning and evaluation efforts as implemented through Winship's Strategic Plan have fostered
growth across the cancer research enterprise with increasing numbers of basic cancer research projects
translating into investigator-initiated clinical trials, increased clinical trials enrollment supporting the state of
Georgia catchment area, and expansion of team science with successful programmatic grant submissions
including lung SPORE, P01, and a myeloma SCOR award. Winship is guided by internal and external experts
including an External Advisory Board (EAB), which is composed of a renowned group of cancer center directors,
program leaders, researchers, and administrators from other NCI-designated cancer centers across the country.
The EAB is charged to provide critical evaluation of Winship's progress on an ongoing basis and guide the
development and implementation of the strategic plan. The EAB meets annually at Winship to review and critique
Winship's progress, plans, and major decisions. In addition, Winship also engages EAB members for input on
important topics and key decisions throughout the year.